Social Health, Activity Behaviors, and Quality of Life among Young Adult Cancer Survivors: A Longitudinal Study

Abstract
Approximately 70,000 adolescents and young adults are diagnosed with cancer between the ages of 15-39 in
the U.S. every year. Due to their age and life stage, the experience of a cancer diagnosis as a young adult
(YA) can lead to a cascade of emotional and physical challenges. A key obstacle faced by YA cancer patients
is impaired social health, a complex construct that includes perceived social belonging, social support, and
social network composition. YA patients report social health challenges such as maintaining existing and
forming new social relationships after diagnosis, which may contribute to poor quality of life post-cancer.
Diminished social health is a major risk factor for poorer health in the general population and has been found to
reduce health-promoting behaviors such as physical activity, in part because of the lack of healthy
opportunities and support that social contacts can provide. Cancer patients clearly benefit from greater levels
of physical activity and lower levels of sedentary time as these are associated with improved quality of life,
longer periods of disease-free survival, and lower mortality. Thus, understanding the relationships between
social health, physical activity, and quality of life is critically important for YA cancer patients, as the impaired
social health experienced by these patients may reduce their activity levels and endanger long-term health
outcomes. The overall hypothesis is that social health in YA is negatively impacted following a cancer
diagnosis, and that detriments in social health influence subsequent physical activity behaviors and
survivorship quality of life (emotional well-being and physical function). In the proposed study, we will
comprehensively prospectively assess social health over 12 months and examine its influence on activity
behaviors and quality of life. Assessment will begin proximal to diagnosis when changes in social health are
likely to initiate for YA cancer patients, with subsequent follow-ups at 3, 6, and 12 months. This longitudinal
design will enable the examination of the dynamic changes in social health during and after therapy and its
predictive influence on physical activity and quality of life. The Specific Aims are: Aim 1: we will characterize
the trajectories of social health in YA cancer patients and assess their influences on quality of life in
survivorship; Aim 2: we will investigate the longitudinal associations between social health and activity
behaviors in YA cancer patients and test the mediational and reciprocal relationships between social health,
activity behaviors, and quality of life; Aim 3: we will explore demographic and clinical moderators of the
relationships between social health, activity behaviors, and quality of life. Understanding the mechanistic
processes by which social health impacts activity behaviors and quality of life will inform the development of
effective intervention strategies to foster social health and improve healthy survivorship for this at-risk and
vulnerable population.

Public health relevance
Narrative Social challenges are a major issue for young adult cancer patients (18-39 years old). Impairments in social relationships, referred to as social health, may decrease physical activity after a cancer diagnosis, leading to poorer quality of life after treatment and recovery. This study will investigate the relationships between social health, physical activity, and quality of life to expand our understanding of their interrelations to inform intervention strategies to foster healthy survivorship for young adult cancer patients.